Enhancement, mapping, and validation of viral vectors for primate optogenetics

PROJECT SUMMARY
Mapping the visual and visuomotor circuits of the brain using opsins and other actuators to target and control
neurons is a central goal of modern neuroscience. Actuators have become key to studying neuronal circuits,
modeling brain disorders, and developing new therapies. Neural actuator applications to research in rodents and
other small animals have achieved great success. In primates, however, these approaches have yet to be
transformative. The main problem is that viral vectors are required to deliver actuator genes, but both viral
transduction and gene expression have been unreliable across, and even within, primate labs. Efficacy is
hindered by the complex innate and adaptive retaliatory immune response in primates, and even when the
approach does work, cell-type specificity is lacking. The overall purpose of this project is to incorporate recent
advances in virology, gene therapy, and immunology to maximize viral transduction, maintain chronic gene
expression, and gain cell-type specificity through retrograde transportation of viruses in visual circuits of the
macaque brain. Throughout the project, optogenetics is the actuator-mediated intervention and the visual-
oculomotor system is the testbed. We focus on two viruses that provide retrograde transport: retrograde adeno-
associated virus-2 (rAAV2-retro) and fusion glycoprotein-E pseudotyped lentiviral vector (NeuRet). Each will
deliver genes encoding the Red-activatable Channelrhodopsin (ReaChR). Our team, spanning Duke, NYU, and
UNC-Chapel Hill, has extensive expertise in vector technology and macaque neurobiology. Aim 1 is dedicated
towards the maturation of pharmacological regimens that modify both arms of the primate's immune system to
enhance viral transduction and promote long-term constitutive expression of opsin transgenes. Aim 2 will
establish comprehensive expression maps of retrogradely transduced neurons. This mapping is a critical step
toward providing cell- and circuit-level specificity and supplies a means for physiologically identifying neurons,
through phototagging, based on their anatomical connectivity. Aim 3 will use phototagging paired with projection
targeting to identify and neurophysiologically characterize neurons contributing to specific circuits within the
visual and visuomotor circuitry of the macaque brain. In combination, this work will enhance the efficacy of viral
vectors for neuroscientific research of the macaque visual and visuomotor system, provide both anatomical and
functional validation of the developed protocols, and provide new insights into the functional role these specific
circuits serve in vision and visuomotor behaviors. Finally, this project will provide fundamental insights for
improving human gene therapies that depend on viral delivery of therapeutic genes.

Public health relevance
Narrative A revolution in neuroscience has been the ability to control nerve cells with light; this is made possible by using viruses to deliver special genes to the cells. Such “optogenetic” technologies were developed using rodents, but they remain unreliable in non-human primates, the best animal model for understanding the human brain. We aim to rigorously enhance, map, and validate the efficacy of new viral methods for controlling neurons in the visual system of the primate brain to benefit both basic research and gene therapies for visuomotor disorders.